RNase functions in post-transcriptional gene regulation

PROJECT SUMMARY
All life forms must maintain a homeostatic gene expression program, which is achieved
at many different steps in gene expression, including by the degradation of specific
mRNAs and non-coding RNAs. Many evolutionarily conserved RNA processing
enzymes mediate these key post-transcriptional events, with important roles for endo
and exoribonucleases. A number of inherited diseases are caused by mutations in endo-
or exoribonuclease genes, further underscoring their importance for human health.
Eukaryotes use exonucleases for the degradation of most cellular mRNAs and for the 5'
and 3' end processing of many different ncRNAs. In addition, endonucleases target
specific mRNAs as an initiating step in mRNA degradation and other endonucleases
process ncRNAs. This proposal will focus on the functional characterization of
ribonucleases, especially functions in cytoplasmic mRNA degradation.

Public health relevance
PROJECT NARRATIVE A number of human diseases are caused by defects in the enzymes that cleave RNA. All eukaryotes have several of these genes, but what RNAs they cleave and how this causes disease is poorly understood. This study aims to increase understanding of the function of these enzymes, which will eventually provide information that could be used to treat such diseases.